Structural insight into novel mechanisms of type III secretion

Project Summary
Type III secretion systems (T3SSs) are nanomachines that are dedicated to protein export in Gram-negative bacteria.
T3SSs share the same morphology and overall structure and can be functionally classiﬁed into two evolutionary-related
classes: the ﬂagellar T3SS, which promotes bacterial locomotion and motility enabled by the ﬂagellum, and the pathogenic
T3SS, which uses the injectisome to transport virulence proteins into human or animal host cells.
Over the past decade signiﬁcant progress has been made in understanding the structure, assembly and the mode of
operation of T3SS. The principal structural building proteins of the ﬂagellum and the injectisome, from the basal body
embedded in the inner and outer bacterial membrane to the tip of the ﬁlaments protruding from the cell surface, and the
cytosolic components have been extensively characterized. Flagellar proteins and virulence factors (effectors, needle
proteins and translocators) form tight complexes with T3S-dedicated chaperones in the cytosol and are subsequently
targeted speciﬁcally to the export apparatus located at the membrane. Powered by ATP and the proton motive force, the
ﬂagellar proteins and bacterial effectors are then translocated through the channel. Fundamental questions about the
functional mechanisms underpinning these processes remain unaddressed.
We propose to use an integrated approach combining structural, dynamic, thermodynamic, kinetic, biochemical and in
vitro and in vivo functional assays to provide insight into the early events of the translocation process that involve the
recognition mechanisms by chaperones, targeting mechanisms to the ATPase and the sorting platform, selection
mechanisms that control the hierarchical transport of the ﬁlament-forming proteins and the effectors and ultimately the
assembly of the cytosolic part of the machinery. We have extensively characterized over the last years T3S protein
components from the enteropathogenic Escherichia coli (EPEC), the major cause of infantile diarrhea and child mortality
worldwide, as well as from Salmonella sp. commonly associated with food poising. We present here novel ﬁndings supporting
very intriguing hypotheses about the mechanisms used by T3SSs to carry out their function. The speciﬁc aims are
designed to provide atomic-resolution insight into (i) the mechanisms of speciﬁc interactions between and among key T3S
proteins, (ii) the mechanistic basis for targeting of T3S proteins to the export gate, (iii) the “recognition” and “secretion”
signal, and (iv) the assembly and operation mechanisms of the export gate and ultimately of the entire T3S machinery.

Public health relevance
Project Narrative Type III secretion system (T3SS) is encoded by many bacterial pathogens, including Shigella, Salmonella, Bordetella, Pseudomonas, and pathogenic E. coli that are pathogenic for humans and cause diseases such as plague, typhoid fever, bacterial dysentery and common food poisoning.